Prospective Studies Of Phlebotomy Therapy In Hereditary Hemochromatosis

Persons with hemochromatosis were recruited via referral by local physicians or self-referral. Comprehensive care and phlebotomy therapy were offered free of charge regardless of whether subjects met criteria for allogeneic donation. Hemoglobin of 12.5 g/dL(for females) 13.0 g/dl (for males), the regulatory thresholds for blood donation in the U.S., were used as the thresholds for performing phlebotomy, and decreases in the mean corpuscular volume (MCV) and ferritin were used to guide the endpoints of therapy. 606 subjects have been enrolled onto the protocol as of August 30, 2021. 67% of subjects were homozygous for the C282Y mutation in the HFE gene, 68% met eligibility criteria for allogeneic donation, and 58% were previous blood donors. A median of 25 weekly or biweekly phlebotomies (range 7-99) were performed before the ferritin reached the targeted endpoint of 50-150 mcg/L. The majority of subjects (253 of the active cohort of 272) are in the maintenance phase of therapy. The median phlebotomy interval necessary to keep the ferritin at this level during maintenance therapy was 20 weeks. Hemochromatosis donations were safe: no incident seroconversions for agents of transfusion-transmissible disease occurred during 11153 donations made by HH donors from 2002 through 2021. As of August 30, 2021 hemochromatosis donors contributed 379 units of red cells since last annual report, comprising 10% of the units collected for allogeneic use in the NIH Clinical Center, and 97 units distributed for research use to NIH investigators from HH donors who did not meet standard allogeneic eligibility criteria. Family member screening and counseling were facilitated by concentrating the care within the Blood Center. Our data demonstrate that hemochromatosis subjects can safely and significantly augment the allogeneic blood supply. Provision of phlebotomy therapy in the Blood Center, unrestricted by considerations of insurance reimbursement or suitability for donation, can improve access to care and remove incentives for incomplete risk disclosure. Data from this study have been presented at numerous national meetings, with emphasis on the safety, efficacy, and operational impact of making hemochromatosis donor blood available for transfusion. Such presentations and ensuing debate have had national impact, as reflected in the increasing number of Blood Centers that have instituted hemochromatosis donor programs. Evaluations performed to date in this cohort indicate that there is a higher than expected incidence of thyroid abnormalities in hemochromatosis subjects, most commonly subclinical hypothyroidism. Thyroid function abnormalities were found in 23.2% of female subjects with homozygosity for the C282Y HFE mutation. A series of cardiology studies in these patients indicated that C282Y homozygotes have a statistically increased incidence of mild, subclinical abnormalities in atrial contractility and exercise-associated arrhythmias when compared to normal subjects, and these changes may be associated with elevated serum markers of oxidative stress. Left ventricular contractility and response to stress were found to be normal in C282Y homozygotes compared with control subjects. A comprehensive analysis of arthritis in these subjects revealed that 12.0% (48/399) C282Y-homozygous versus 3.7% (7/190) non-homozygous subjects underwent a total of 51 total hip, 31 total knee, and 11 total ankle replacements. The frequency of total joint replacement was significantly greater in C282Y-homozygotes than in the control group. The cumulative risk of total joint replacement hemochromatosis subjects was 31%. Among C282Y homozygotes, the risk of total joint replacement was markedly greater in subjects with initial ferritin levels greater than the median value of 735 mcg/L. Among the estimated 23,966 Caucasian U.S. males age 40-79 undergoing total hip replacement each year, the data suggest that 3-4% are C282Y-homozygous.